Support Services to EDRN in the National Cancer Institute

This contract task order provides support services to the Early Detection Research Group located within the Division of Cancer Prevention at the National Cancer Institute.